National Pediatric Rehabilitation Resource Center: Administrative Oversight

Project Summary (Administrative Oversight)
The PI/Director of the proposed National Pediatric Rehabilitation Resource Center (PedRehab Ctr) will have
primary responsibility for the overall administrative oversight with clear distribution of shared administrative and
scientific leadership responsibilities among the center's multidisciplinary team of 6 scientists, each of whom
serves as Lead for one of the designated core components: Didactic Interactions, Mentored Collaborative
Opportunities, Pilot Studies, Techniques Development, and Promoting Center Expertise. All team members are
engaged in ongoing clinical trials pediatric rehabilitation research, share a history of productive interdisciplinary
collaborations, and assume national leadership roles in organizations and research networks in pediatric medical
rehabilitation. The specific aims for Administrative Oversight are:
1) to ensure that PedRehab Ctr core components function well, interact frequently, and strategically utilize
their resources to achieve the overall goals for PedRehab Ctr;
2) to engage the PedRehab Ctr team of scientists in a highly efficient, stimulating, and rewarding manner
that welcomes their engagement in the administrative aspects of Ped Rehab Ctr;
3) to convene an independent National Advisory Board to assist in reviewing and improving plans and
operations, in ways that encourage Board members to join us as colleagues in areas relevant to their research
expertise;
4) to achieve consensus about and then establish a continuous information system (open, verifiable, easy
to summarize) that can yield useful, timely data about our progress and impact on the targeted research
community; and
5) to promote a scientifically vibrant and new P2C in pediatric rehabilitation that will interact with and
strengthen the national network of infrastructure support centers sponsored by the Eunice Kennedy Shriver
NICHD's National Center for Medical Rehabilitation Research.
Our PedRehab Ctr team strongly endorses a model of lateral, shared, and joint decision-making among team
members. We seek to minimize administrative burden and avoid duplicative efforts for our team members and
support staff as well as for those who use our core's resources. Above all, we seek to leverage the available
funds for the PedRehab Ctr to yield maximal benefit for clinical pediatric rehabilitation research.